Neuropeptide Regulation of Enteropancreatic Function

The function of the Animal Core is to produce and maintain all of the animals required for the scientific project for this and several other program project grants. The specific services of the Animal Core personnel include 1) Providing the highest quality animal and veterinary care, 2) Production of transgenic and knockout mice, 3) Performing experimental inoculations, neurologic scoring of animals, data collection, and tissue collection, 4) Performing dosing and toxicology studies for novel drugs, 5) Providing transportation of animals and tissues between the laboratory and the animal facility, 6) Production of antibodies in mice and rabbits for experimental use, 6) Providing all animal care and veterinary care, 7) Production of large volumes of scrapie infected hamster and mouse brains for purification, 8) Providing cryopreservation of the various mouse lines. The Animal Core operates in two purpose-built facilities in the Hunters Point area of San Francisco, approximately 7 miles from the main UCSF campus. Its activities are directed by Dr. Prusiner and Dr. Pierre Lessard, a laboratory animal veterinarian. Building 830B is a new nine room transgenic mouse breeding facility that houses our large breeding colony. Building 830 houses all the experimental animals in 21 rooms, under BSL-2 and 3 biocontainment. It houses on average 10,000 mice, 400 hamsters, and 8 rabbits. The facility is inspected annually by USDA, and bi-annually by UCSF/IACUC.